Utilizing beige fat to improve muscle function after rotator cuff repair

123
PROJECT DESCRIPTION
45
Rotator cuff (RC) tears are an extremely common cause of shoulder pain and
disability. Up to 50% of patients greater than the age of 65 years of age have evidence
6789
of a RC tear. In addition, patients with small asymptomatic cuff tears tend to progress to
larger, symptomatic tears. The outcomes of surgical repair of small RC tears are good,
but there has been limited success in the surgical treatment of massive RC tears.
11 01
Massive RC tears have been linked with fatty infiltration of the rotator cuff muscles.
Patients with large RC tears who develop fatty infiltration have poorer clinical outcomes
11 23
and higher rates of failure after attempted repair. We have previously found that a newly
discovered stem cell population-fibro/adipocyte progenitor (FAP) cells-is critical in the
11 45
development of fatty infiltration after RC injury. Further, these cells share similar
expression patterns with the beige adipocyte lineage, a distinct cell population that has
11 67
unique thermogenic and metabolic capabilities that could improve muscle function.
11 89
The study will leverage our well-studied animal model and a novel repair model to
evaluate the mechanism by which FAP cells can improve muscle function through
22 01
differentiation into a beige fat phenotype in mouse and human tissue. Understanding the
relationship between FAP cells and beige adipocytes and utilizing these cells in
endogenous and exogenous treatment strategies could help improve muscle quality in
RC repair as well as other muscle injury states.

Public health relevance
123 PROJECT NARRATIVE 456 Rotator cuff (RC) tears are the most common shoulder injury, affecting up to 50% of the population over 65 years of age. Changes in the muscle can guide clinical outcomes after injury and repair. The proposed study seeks to develop novel endogenous 7 treatment strategies to improve muscle quality after RC repair. The results of this study will improve our knowledge of muscle injury and allow for improved and novel treatments of RC injury.